Targeting monocyte allorecognition to achieve allograft acceptance

Abstract:
Over the past decades great progress has been made in solid organ transplantation in
improving 1-year allograft survival rates, but long-term allograft survival has not improved
significantly. Despite the use of maintenance immunosuppression, chronic rejection is one of
the main drivers of graft failure in addition to the side effects of maintenance
immunosuppressive therapy. Long-term allograft acceptance without the need for maintenance
immunosuppression is therefore an unmet clinical need. We have recently discovered that
monocyte allorecognition depends on the key step of sensing polymorphic donor SIRPa by
CD47 on recipient monocytes. This leads to formation of donor-specific monocyte memory and
differentiation of monocytes to mono-DC, which drive rejection and graft pathology. CD47ko
mice display monocyte unresponsiveness and less graft pathology, while a donor SIRPa
mismatch in human renal allograft recipients is associated with increased 1-year graft fibrosis
and shorter 7-year graft survival.
In this grant application we hypothesize that long-term allograft acceptance can be
achieved by combining T cell costimulation blockade with inhibition of monocyte
allorecognition via CD47. The goals of this proposal are a) to develop a translatable model of
blocking CD47 in addition to T cell costimulatory blockade to induce long term graft acceptance
(Aim 1), and b) to investigate the mechanisms of monocyte unresponsiveness in the absence of
CD47 signaling to uncover novel targetable pathways (Aim 2).
These studies are significant as they address the unmet clinical need of long-term
allograft acceptance without excessive side effects of conventional immunosuppression and are
using a novel, specific approach to suppress the innate immune system in addition to the
adaptive immune system. Insights gained from these studies are likely to have direct human
relevance and could potentially be tested in the clinic.

Public health relevance
Project Narrative Improvement of long-term allograft survival without the side effects of maintenance immunosuppression is an unmet clinical need. In this proposal we are investigating if blocking innate allorecognition via CD47 in addition to T cell costimulatory blockade can induce long-term allograft acceptance in a heart transplantation model in mice. Investigating monocyte unresponsiveness after targeting CD47 will inform us of potential novel targets to prolong allograft and patient survival.